SaTScan: Spatial Scan Statistic Surveillance Software II

DESCRIPTION (provided by applicant): SaTScan is a free statistical disease surveillance software package implementing the spatial, temporal and spatio-temporal scan statistics. It is used by many scientists and public health officials across the United States and around the world for geographical disease cluster detection and evaluation, and for the early detection of disease outbreaks. With the software, it is possible to determine whether disease cases are randomly distributed over space and/or time, or whether there are statistically significant spatial, temporal and/or spatio-temporal clusters with more (or fewer) cases than expected. Critically, it adjusts for the multiple testing inherent in the many possible cluster locations and sizes evaluated, as well as for covariates. As the number of users increase, there is an increasing number of requests for new SaTScan features and functionalities, including integration with geographical information systems and statistical software packages, graphical output functionalities, power evaluation tools, more general analysis options, and easy to use training material. In this project, we propose to further develop and maintain the SaTScan software to fulfill many of these needs. PUBLIC HEALTH RELEVANCE: The SaTScan disease surveillance software has around 13,000 registered users, including over 800 at federal (CDC), state and local public health departments across the United States. Additional features, functionalities and training material will enable users to apply the software in new and innovative ways, as well as more efficiently.

Public health relevance
The SaTScan disease surveillance software has around 13,000 registered users, including over 800 at federal (CDC), state and local public health departments across the United States. Additional features, functionalities and training material will enable users to apply the software in new and innovative ways, as well as more efficiently.